Determination of structure-function relationships and role in virulence of a MerR-type regulator that mediates zinc tolerance in Streptococcus mutans

Abstract
Dental caries is the most prevalent chronic infectious disease, with an estimated treatment cost of ~$70
billion/year. While a multifactorial disease, Streptococcus mutans is recognized as a keystone caries pathogen
because of its capacity to modulate the oral biofilm in a way that promotes the establishment of a highly
acidogenic (cariogenic) microbiota. The trace metals iron, manganese, and zinc (Zn) play structural, catalytic,
and regulatory roles in proteins and so are essential to all forms of life. Conversely, these same metals are
toxic when in excess such that the ability to maintain metal homeostasis is a critical aspect of host-pathogen
interactions. The toxicity of Zn derives from its top position in the Irving-Williams series of metal stability, which
allows Zn to avidly bind to non-cognate metalloproteins rendering them nonfunctional. Because it has both
antimicrobial and immunomodulatory properties and relatively low toxicity to mammalian cells, Zn has been
used for decades in medicine, including incorporation into oral health products for the treatment of gingivitis,
halitosis, and prevention of calculus formation. Recently, it was discovered that S. mutans is intrinsically and
substantially more tolerant to toxic levels of Zn than all other streptococci and that this high tolerance is
mediated by a unique P-type ATPase exporter that has been named ZccE. Expression of zccE is controlled by
a unique MerR-type regulator, ZccR for zccE regulator, that strongly activates zccE transcription in response to
high Zn stress. Because both ZccE and ZccR are unique to S. mutans, the Lemos lab proposes that both can
be targeted for the development of a Zn-based therapy tailored against S. mutans. While other projects in the
Lemos lab are exploring the antimicrobial potential of ZccE, the specific aims of this application center around
the ZccR regulator. The goals of this application are to determine the structure-function relationships of ZccR
and explore its potential as an antimicrobial target. To accomplish these goals, the PI will (i) use
crystallography and computational-based approaches to determine the structure of ZccR and identify its critical
functional residues, and (ii) utilize the rat model to determine the contribution of ZccR to oral biofilm
colonization and caries development alone or in combination with topical Zn treatment. Knowledge gained from
this study will facilitate the structure-guided design of small molecule inhibitors for ZccR and reveal the
potential of targeting mechanisms of Zn homeostasis to combat S. mutans infections, with the long-term
objective of developing novel therapies for the prevention of dental caries and treatment of systemic S. mutans
infections (i.e., infective endocarditis). This work will be conducted in a highly supportive and collaborative
research environment with Aim 1 establishing a collaboration between the Lemos and McKenna labs.
Moreover, the comprehensive training plan provided will accelerate the PI's academic and scientific growth
through participation in formal course work and workshops, opportunities to learn new methodologies,
mentoring students, establishing new collaborations, and improving scientific writing and presentation skills.

Public health relevance
Narrative Dental caries is one of the most prevalent chronic diseases in the world and the oral bacterium Streptococcus mutans is the major etiological agent of this multifactorial disease. We recently discovered that S. mutans tolerates unusually high concentrations of zinc by utilizing the ZccE exporter and ZccR regulator pair. Because zinc can be safely delivered in high concentrations via oral healthcare products, a better understanding of the importance of ZccR to dental caries and determination of ZccR structure can help us devise new anti-caries therapies by specifically targeting S. mutans without damaging either host cells or disturbing the bacteria associated with oral health.